Algorithm and software for predicting the structure and degrading efficiency of PROTACs

The use of PROteolysis TArgeting Chimeras (PROTACs) has become an important technology for modulating
a target protein by degradation. PROTACs are heterobifunctional molecules that connect a ligand bound to a
protein of interest (POI) to an E3 ubiquitin ligase (E3) recruiting ligand with an optimal linker. Degradation is
initiated when PROTAC promotes the POI and the E3 ligase to form a ternary complex. Since the two proteins
are expected to favorably interact with each other and also with a flexible linker, the design of the optimal linker
that yields the desired POI-PROTAC-E3 complex is a challenge, and current computational tools provide limited
help. We address three important problems leading to improved PROTAC design. First, we have recently
developed and tested an effective protocol for predicting high accuracy models of POI-PROTAC-E3
ligase ternary complexes. Our Aim 1 is to implement the protocol as an easy-to-use computer program
for licensing. The method is based generating two large ensembles (“clouds”) of half-linker
conformations, one linked to the warhead bound to the POI and the other to the “anchor” ligand bound
to the E3 ligase, and use a modified version of our efficient protein-protein docking program PIPER to
directly sample conformations that have a favorable relative orientation of the two proteins and in which
the end points of some half-linkers are close to each other. After local refinement, each resulting
conformation yields a feasible structure of the ternary complex, including the linker. After removing
poses that do not assure accessibility to ubiquitination sites, the new method consistently generates
high accuracy models among the top few predictions. It was shown that in most cases the best model
can be selected by clustering a set of models generated for different PROTACs with the same E3 ligase
and target protein. In Aim 2 we explore the use of both Monte Carlo and molecular dynamics methods
to generate ensembles of structures around the models in order to determine the stability of the ternary
complex and to predict its dissociation constant Kd and the level of binding cooperativity. Increasing
the latter tends to reduce the hook effect. A highly efficient Monte Carlo method, specific to applications
to PROTAC ternary complexes, is also developed. In Aim 3 we compare maximal degradation
percentage (Dmax) and half maximal degradation concentration (DC50) values, measured in cellular
essays available in the literature, to calculated Kd and cooperativity values in order to separate the
impact of bioavailability related linker properties such as membrane permeability and solubility.
Methods from the three aims will enable predicting POI-PROTAC-E3 structures, Kd and cooperativity
values, and the level of cellular degradation on the basis of the two proteins, their ligands, and the
chemical structure of the linker. Thus, the software package will be useful for rational PROTAC design
as demonstrated by enquiries from companies working on development of related technologies.

Public health relevance
The use of PROteolysis TArgeting Chimeras (PROTACs) has become an important technology for modulating a protein of interest (POI) by degradation, but computational tools for analysis and design need substantial further development. Here we address some of the important problems, namely the modeling, stability, and degradation efficiency of POI-PROTAC-E3 ligase ternary complexes.